Map Paravascular Fluid Dynamic Signatures of Key Aging and AD Processes Using Dynamics Diffusion-Weighted Imaging

Abstract
Alzheimer’s disease (AD) is characterized by the accumulation of amyloid-beta (Aβ) and tau
pathologies. Mounting evidence from preclinical studies suggests that disruption of the
paravascular cerebrospinal fluid (pCSF) clearance pathway (glymphatic system) contributes to
Aβ and tau aggregation. These studies further highlighted a reliance of pCSF circulation on
vascular functions, where spontaneous hypertension led to reduced pCSF flow. However, it is
unclear whether similar phenomena exist in humans and how pCSF dynamics change with aging,
essential hypertension, and AD. Human studies of the glymphatic system have proven to be
challenging due to the lack of safe tracer-free imaging approaches. Recently, a novel clinically
feasible imaging technique, dynamic diffusion-weighted imaging (dDWI), has been developed by
the PI, which yields reproducible quantitative metrics of pCSF movement within the glymphatic
system. The quantitative metrics can simultaneously assess the volume and dynamics of pCSF
near the major and pial arteries – the influx of the glymphatic flow. As one of the early human
studies in this glymphatic pathway, our results of a cohort aged 18 to 82 revealed significantly
enlarged paravascular space and remarkably altered pCSF pumping in the older brain, the extent
of which is associated with cognitive decline. Built upon the novel technique, intriguing preliminary
results, and our team’s strong expertise in AD research, the overall goal of the proposal is to map
pCSF signatures of key aging and AD processes. Our central hypothesis is that although aging
and hypertension are two culprits of compromised pCSF, AD show disease-specific pCSF
abnormalities related to pathogenesis. We will leverage the state-of-the-art neuroimaging
techniques (e.g., dDWI, Aβ/tau positron emission tomography [PET]) and our large longitudinal
clinical database of the Indiana Alzheimer’s Disease Research Center (IADRC) to achieve the
following aims: (1) Map pCSF signatures of healthy aging. (2) Map pCSF signatures of aging with
hypertension. (3) Map pCSF signatures of AD and determine their associations with Aβ/tau
aggregation. The success of the three aims will determine whether fluid clearance function shows
similar or distinct alterations in healthy aging, hypertension, and AD. Such knowledge is critical
for identifying disease pathways and developing novel therapeutics. The new imaging technique
is expected to provide valuable and translational imaging biomarkers for detecting and monitoring
dysfunctional fluid clearance in AD and be applied to study other neurodegenerative diseases of
high clinical impact.

Public health relevance
Project Narrative It was discovered recently that the glymphatic system is one of the brain’s major routes of waste clearance, and its dysfunction may contribute to the pathogenesis of Alzheimer's disease (AD). In humans, however, how glymphatic function is affected in aging and AD is poorly characterized due to a lack of detecting tools. In this project, we will apply a novel noninvasive imaging technique developed by the principal investigator to map glymphatic alterations of key aging and AD processes.